REPOSITORY SERVICES FOR THE SAFE PASSAGE STUDY (PASS)

The contract will support the storing, monitoring, and distributing of biospecimens collected by the scientific centers/divisions of the NICHD. The NICHD conducts studies focusing on child health and human development and as such has generated and will continue to generate a collection of human biospecimens pertaining to these research activities. Currently, the NICHD requires specimen storage services that will provide a functional inventory system coupled with proper storage and disbursements of these biological specimens to four NICHD divisions, the division of Intramural Population Health Research, the Maternal and Pediatric Infectious Disease Branch, the Pregnancy and Perinatology Branch, and the Division of Intramural Research.

The purpose of this contract is specimen collections on the PASS (Prenatal Alcohol and SIDS and Stillbirth Network. Investigates the role of prenatal exposure to alcohol in SIDS (Sudden Infant Death Syndrome) and adverse pregnancy outcomes, such as stillbirth and fetal alcohol spectrum disorders.